Probing the mechanisms of epithelial barrier restoration in the distal lung

PROJECT SUMMARY
Respiratory diseases like the Acute Respiratory Distress Syndrome, Idiopathic Pulmonary Fibrosis and Chronic
Obstructive Pulmonary Disease produce significant morbidity and mortality worldwide. While each of these
diseases are distinct, they all have in common a failure to maintain or repair lung alveoli. Thin, delicate alveolar
type 1 (AT1) cells encompass greater than 95 percent of the alveolar gas exchange surface, interspersed with
cuboidal, surfactant-secreting alveolar type 2 (AT2) cells in a monolayer epithelium. A minor subset of AT2 cells
serve as the principal stem cells that renew alveoli throughout the lifetime. They function to regenerate the
epithelium after injury, and there is some evidence to suggest that their disfunction underlies chronic forms of
respiratory disease. Establishing a deep understanding of the biology of AT2 stem cells may lead to new
pharmacological and cell-based therapies to treat these diseases. Despite recent, significant advances in lung
alveolar stem cell biology, the physiological behavior of AT2 stem cells and the molecular mechanisms that
regulate this behavior have proven to be challenging to define. We developed a mouse genetic system to study
dynamic activation of AT2 stem cells in vivo that employs targeted ablation of AT1 cells using Diphtheria toxin.
As expected, we found that AT2 cell self-duplication was rapidly induced upon AT1 cell ablation, however, this
was preceded by immediate and widespread AT2-to-AT1 transdifferentiation. Our results reveal a previously
unappreciated role for a (non-stem) AT2 cell population in rapidly regenerating the alveolar barrier. We
hypothesize that alveolar repair involves a two-step mechanism in which direct transdifferentiation of AT2 cells
into AT1 cells initially restores barrier integrity and is followed by self-duplication of AT2 stem cells. The proposed
project aims to further probe the mechanisms and physiological importance of this ultra-rapid restoration of the
alveolar gas exchange and barrier surface. Our findings will help to establish a foundational model of epithelial
regeneration in lung alveoli, and will inform practical strategies for manipulating AT2 stem cells in therapeutic
applications.

Public health relevance
PROJECT NARRATIVE Our research focuses on the stem cells that maintain our lungs capacity for gas exchange throughout the lifetime. By understanding the behavior and molecular regulation of these stem cells, we may be able to harness their regenerative potential to cure diseases that cause respiratory failure.